Collaborative Resarch in Computation Neuroscience (CRCNS)

To support logistical and administrative requirements in support of the review of applications in response to the NSF/NIH PA on Computational Neuroscience.